Elucidation of the first interspecies chemical signaling mechanisms in Capsaspora owczarzaki--the predator of a human pathogen and a model for the evolution of animal multicellularity

Project Summary / Abstract
Capsaspora owczarzaki is a protozoan that may control a neglected tropical disease and reveal the earliest
animal cell-cell signaling mechanisms. However, little is known about this organism at a chemical level. Capsas-
pora lives inside Biomphalaria snails (the vectors that transmit schistosome worms that cause schistosomiasis).
Capsaspora hunts and kills schistosomes, making it a promising biocontrol agent. However, no one knows which
molecules Capsaspora senses to colonize its snail host, nor how it senses its schistosome prey. Furthermore,
Capsaspora is one of the closest living relatives of animals, with which it shares signaling and adhesion genes.
It exhibits reversible aggregation and chemotaxis, reminiscent of human neural crest cells, immune cells, and
metastatic cancer cells. Therefore, it is a phylogenetically relevant model to study how multicellular phenotypes
in animals evolved and act in healthy and disease states. However, no one has found which molecules regulate
Capsaspora’s adhesion and chemotaxis phenotypes to determine if its mechanisms are conserved with those in
animals. For Capsaspora to reach its potential as a biocontrol agent and to reveal insight into the evolution of
animal multicellularity, its mechanisms of chemical signaling must be uncovered.
The proposed research program will discover the molecular mechanisms that regulate two phenotypes, each of
which is relevant both to killing schistosomes and to understanding the evolution of multicellular traits in animals.
First, Capsaspora forms aggregates in response to snail serum, which is notable for two reasons: (1) it is the
only Capsaspora response to a snail host factor, presumably enabling Capsaspora to recognize its snail host
environment, and (2) it is the only regulated cell-cell adhesion process in Capsaspora, which is the only non-
animal with complete integrin and cadherin adhesion complexes. Therefore, discovery of the mechanism of se-
rum-induced aggregation may reveal both how Capsaspora colonizes its host and whether or not regulated
animal cellular adhesion mechanisms were active in animals’ common ancestor. Second, Capsaspora migrates
toward schistosome prey, which is notable for two reasons: (1) it is the only known avenue by which Capsaspora
senses schistosomes, and (2) it is the only reported chemotaxis behavior in the closest relatives of animals (the
holozoans). Therefore, discovery of the chemoattractant and response may reveal how Capsaspora hunts schis-
tosomes and whether or not animal chemotaxis mechanisms were active in animals’ common ancestor.
In both projects, the cue molecule and the Capsaspora receptor will be identified. Subsequent work will decipher
how the signal is transduced. Finally, the significance of these phenotypes for snail colonization and schistosome
killing will be tested in vivo, and the evolutionary conservation of these signaling mechanisms with present-day
animals will be examined. Discovery of the signals and mechanisms that trigger Capsaspora aggregation and
chemotaxis may reveal essential traits for Capsaspora to decrease schistosomiasis infections. Furthermore, this
work may reveal the most fundamental mechanisms of regulated multicellularity in animals.

Public health relevance
Project Narrative The proposed research aims to uncover information that is essential to develop a new schistosomiasis control strategy. The work also aims to determine which molecules are fundamentally required for the evolution of animal cellular adhesion and chemotaxis—important phenotypes for a range of diseases from immune disorders to cancer metastasis. Because this project is uniquely applicable both to a neglected tropical disease and to some of the most common diseases in the U.S., it is relevant to human health and the NIH’s mission to reduce illness.